MAINTAIN, ANALYZE & DISSEMINATE MRI BRAIN IMAGE DATABASE

This project is to maintain, make secure and make available to qualified investigators he existing Cincinnati MR Imaging of Neuro-Development (CMIND) database and associated user-friendly quary graphical user interface (GUI) and web-based platform for clinical and imaging data acquisition to disseminate study data. The CCHMC CMIND was a 5 year study of brain-behavior function in typically normal developing children.